Cajal-Retzius cells and neuronal signaling in postnatal cortical networks

Project Summary
The broad aim of this competitive renewal application is to shed new light on the structure and functions of
the hippocampal network, with a specific emphasis on a rather mysterious and understudied neuronal cell
type, the Cajal-Retzius cell (CR).
The significance of studying these cells is highlighted by literature reports indicating increased densities of
CRs in the hippocampus of a subpopulation of patients suffering from temporal lobe epilepsy, who also
experienced febrile seizures at early ages. This observation has suggested that the physiological process
controlling CR numbers and functions may be involved in the epileptogenic process.
The scientific premise underlying this project relies on two main discoveries made by our laboratory. First,
we have provided unequivocal evidence that hippocampal CRs are a third population of glutamatergic
neurons (in addition to pyramidal and granule cells), which persist in the mature hippocampal network and
are fully integrated in its microcircuits. Second, we have recently found that CRs express the polymodal,
temperature-gated and Ca2+ permeable channel TRPV1.
These discoveries provide unique opportunities to study the physiological and pathological functions of
CRs and of the microcircuits they drive in genetically-altered animals with conditionally increased levels of
TRPV1 expression or conditionally ablated vesicular glutamate transporters.
In particular, we will test the hypotheses that the functional expression of TRPV1 by CRs determines their
densities in the developing hippocampus and/or regulates their synaptic output. Lastly, we will test the
hypothesis that temperatures in the febrile seizure range can impact hippocampal CR-dependent
microcircuits via TRPV1 in vitro and in vivo.

Public health relevance
Project Narrative This proposal plans to study novel molecular mechanisms controlling the density and synaptic functions of Cajal-Retzius cells (CR) in the hippocampal circuit. We will take advantage of transgenic animals to test the broad hypothesis that Ca2+ fluxes generated by the polymodal channel TRPV1 are key signaling events for CR developmentally-regulated decrease and/or for the regulation of their synaptic output. As TRPV1 channels are gated by temperature, these processes may play important roles during febrile seizures.